IGF::OT::IGF NEXT GENERATION SEQUENCING (NGS) TECHNOLOGIES OF ARCHIVED FFPE TISSUE FROM MEN OF AFRICAN DESCENT

NEXT GENERATION SEQUENCING (NGS) TECHNOLOGIES OF ARCHIVED FFPE TISSUE FROM MEN OF AFRICAN DESCENT